The role of VMAT-2 in mediating the impact of HIV-1 protein Tat and methamphetamine on dopamine neurotransmission and behavior

Project Summary
Dysregulation of dopaminergic function due to the HIV-1 transactivator of transcription (Tat) protein has
been implicated in the progression of HIV-1 associated neurocognitive disorders (HAND). Tat mediates
increases in dopamine (DA) release and acts as a negative allosteric modulator for the dopamine transporter
(DAT). In addition to DAT, previous work has identified Tat as a negative allosteric modulator for the vesicular
monoamine transporter (VMAT-2). VMAT-2 functions to repackage DA into vesicles for subsequent release.
Inhibition of VMAT-2 causes dysregulation of DA neurotransmission which can lead to autooxidation of DA and
apoptosis. The psychostimulant methamphetamine (METH), in addition to Tat, inhibits VMAT-2 function. METH
is a highly abused psychostimulant among HIV-1 infected persons. Expression of the Tat protein has been shown
to potentiate METH induced neurotoxicity and behavior. Considering the respective interactions between Tat or
METH and VMAT-2, we hypothesize that the Tat and METH effects on extracellular DA and behavior are
mediated by VMAT-2. We will address this hypothesis by first, determining the role for VMAT-2 in mediating Tat-
induced increases in DA release (Tat alone). We will use fast scan cyclic voltammetry to quantify DA release in
Tat expressing mice. Specifically, we will profile the pharmacological response to a VMAT-2 inhibitor to
determine whether Tat expression alters VMAT-2 function. Second, we will use two different METH
administration models (acute and chronic) and profile the response to the VMAT-2 inhibitor as in the first aim.
Lastly, we will determine whether a VMAT-2 specific inhibitor attenuates Tat-potentiated METH-conditioned
place preference behavior. This will give insight whether VMAT-2 mediates Tat-potentiated METH behavior. The
findings from this proposal will provide key insight into the molecular mechanism by which Tat increases
extracellular DA and determine whether VMAT-2 is a suitable drug target for future therapeutic intervention in
the treatment of METH abuse in HIV-1 infected persons.
.

Public health relevance
Project Narrative The vesicular monoamine transporter (VMAT-2) is critical for maintain dopamine (DA) homeostasis. The proposed research will investigate the role for VMAT-2 in mediating HIV-1 protein Tat and methamphetamine (METH) effects on extracellular DA and behavior, as HIV-1 infected persons are highly susceptible to METH abuse. This work will characterize how Tat and METH interaction with VMAT-2 impacts DA dynamics. This will provide key insight for future therapeutic intervention for METH abuse in HIV-1 infected persons.